Glycemic Profile of Pregnancy Consortium Biostatistics Research Center

PROJECT SUMMARY
Maternal hyperglycemia during pregnancy is a known risk factor for high birthweight, excessive newborn
adiposity, and related pregnancy complications including cesarean delivery, shoulder dystocia and birth injury.
Sequelae of elevated pregnancy glucose are not limited to the perinatal period. Mothers meeting criteria for
gestational diabetes are more likely to develop long-term metabolic disorders including Type 2 diabetes.
Maternal glucose also has an apparent sustained influence on fetal programming, with offspring of
hyperglycemic mothers at higher risk of both excess adiposity and disordered glucose metabolism throughout
childhood and into adolescence. While debate exists as to specific criteria that should be used for diagnosing
gestational diabetes, it is the case that adverse maternal and offspring outcomes related to both
anthropometrics and glucose metabolism, both at delivery and over a decade later, are associated with
maternal glucose values across the continuum. Existing diagnostic criteria for gestational diabetes are based
on measures of maternal glucose, typically at ~28 weeks' gestation. To more fully elucidate maternal glycemia
and identify potential early indicators of gestational diabetes, Clinical Centers comprising the National Institute
of Diabetes and Digestive and Kidney Diseases' Glycemic Profile of Pregnancy Consortium will be charged
with designing a multicenter observational study of pregnant mothers without pre-existing diabetes to richly
characterize maternal glycemic profiles using sensor-based continuous glucose monitoring technology. The
Northwestern University Biostatistics Research Center proposes to serve as a central leadership hub for the
Glycemic Profile of Pregnancy Consortium, coordinating all data-related and operational activities using
cutting-edge resources for study design, planning and conduct, ongoing data monitoring and statistical
analysis.

Public health relevance
PROJECT NARRATIVE The Northwestern University Biostatistics Research Center (NU BRC) will serve as a central leadership hub for the Glycemic Profile of Pregnancy Consortium, coordinating all data-related and operational activities using cutting-edge resources for study design, planning and conduct, ongoing data monitoring and statistical analysis. The NU BRC will develop novel and clinically interpretable statistical models for continuous glucose monitoring data, and will investigate associations between maternal glycemia during early pregnancy with development of gestational diabetes and outcomes at delivery.